GENETIC STUDIES OF CRANIOFACIAL AND LIMB DISORDERS

The overall hypothesis of this proposal is that genetic and environmental factors are involved in normal human craniofacial and limb development and are risk factors for these disorders. The goal of this proposal is to determine those genetic and environmental factors involved in human craniofacial and limb development. The common human craniofacial conditions of craniosynostosis, oral clefts, and mandibulofacial dysostosis, and their associated limb abnormalities will be studied in over 500 patients in the Mid-Atlantic Region during the next five year period. During the last period from 12/1/97 through 11/30/98, we studied a craniofacial syndrome, Saethre-Chotzen. Thirty-two unrelated patients with features of Saethre-Chotzen syndrome, a common autosomal dominant condition of craniosynostosis and limb anomalies, were screened for mutations in TWIST, FGFR2, and FGFR3. Nine novel and three recurrent TWIST mutations were found in 12 families. Seven families were found to have the FGFR3 P250R mutation, and one individual was found to have an FGFR2 VV269-270 deletion. To date, our detection rate for TWIST or FGFR mutations is 68% in our Saethre-Chotzen syndrome patients, including our five patients elsewhere reported with TWIST mutations. More than 35 different TWIST mutations are now known in the literature. The most common phenotypic features, present in more than a third of our patients with TWIST mutations, are coronal synostosis, brachycephaly, low frontal hairline, facial asymmetry, ptosis, hypertelorism, broad great toes, and clinodactyly. Significant intra- and interfamilial phenotypic variability is present for either TWIST mutations or FGFR mutations. The overlap in clinical features and the presence, in the same genes, of mutations for more than one craniosynostotic condition-such as Saethre-Chotzen, Crouzon, and Pfeiffer syndromes-support the hypothesis that TWIST and FGFRs are components of the same molecular pathway involved in the modulation of craniofacial and limb development in humans.